STRONG HEART STUDY (SHS): OUHSC COORDINATING CENTER - TASK AREA B (B.1 AND B.3)

During Task Area B.1., the Coordinating Center shall provide qualified staff to support and coordinate the planning activities and preparations for the Phase VII exam. The Coordinating Center shall work collaboratively throughout the period of performance with the SHS Field Centers and with ancillary study investigators.

During Task Area B.3, the Coordinating Center shall provide coordination as needed for pilot research projects in tribal communities, which will be funded as subcontracts and administered by the FCs. These exploratory, initial feasibility pilot studies will be conducted within the tribal communities of each FC.